Socioeconomic Heterogeneity in the Impact of Psychiatric Care: A Secondary Analysis of the RAISE-ETP Trial for Patients with First-Episode Psychosis

Using data from the NIMH-sponsored RAISE-ETP trial, this study examines socioeconomic barriers to the effec-
tive provision of psychiatric care. RAISE investigators found modest beneﬁts of an early-intervention program
for patients with ﬁrst-episode psychosis. Our preliminary analysis suggests a large and statistically signiﬁcant
gap in which only high-SES patients beneﬁtted from the intervention. We will examine possible explanations for
this pattern, including SES differences in initial mental health, stigma, treatment adherence, cognition, substance
abuse, and economic empowerment. Finally we will quantify the contribution of this pattern for the SES gap in
mental health. This inquiry is distinct from any analysis that the RAISE investigators have proposed or carried
out.

Public health relevance
This study uses data from the RAISE-ETP trial to examine the socioeconomic barriers to effective schizophrenia treatment. It considers the channels through which SES may moderate the impact of care and quantiﬁes the contribution of this channel to health inequality. This inquiry will explore a previously-unexamined source of mental health disparities.